Metabolic Obesity Phenotypes and Obesity-related Cancer Survival

PROJECT SUMMARY. The incidence of obesity-related cancer (ORC) continues to increase rapidly despite a
decrease in overall cancer incidence; currently ORCs constitute over 40% of all cancers making them a
significant public health concern. Strong evidence suggests that both obesity and metabolic dysfunction (often
defined as the presence of hyperglycemia, hypertension, dyslipidemia, or adiposity) increase the risk of ORCs.
However, there is limited research on the association of metabolic dysfunction with survival after ORC. The
impact of cancer and cancer treatment on metabolic health after cancer diagnosis is also largely unknown.
Additionally, although metabolic dysfunction is usually highly correlated with obesity, there is emerging
evidence that up to a third of normal weight individuals have some degree of metabolic dysfunction. Metabolic
obesity phenotypes, defined according to both presence of metabolic syndrome criteria and obesity status
(measured by BMI), is an emerging way to assess metabolic dysfunction beyond obesity alone. The goal of
this F30 project is to better understand the impact of cancer on metabolic health, and the relationship of
metabolic dysfunction with survival after ORC diagnosis. Firstly, I will evaluate the association between
metabolic dysfunction at ORC diagnosis, measured by metabolic obesity phenotypes, and ORC-specific and
overall survival (Aim 1). To accomplish this aim, I will leverage the European Prospective Investigation into
Cancer and Nutrition (EPIC)-InterAct case-cohort, which comprises detailed data on metabolic biomarkers and
cancer diagnoses in several ORC patients (N~1,777). Among participants with ORC, I will ascertain
associations between metabolic obesity phenotypes and survival using Cox proportional hazards regression
models, adjusting for relevant covariates. Secondly, I aim to identify clinicodemographic factors associated with
both metabolic health and metabolic obesity phenotype worsening (Aim 2). Using data extracted from
electronic medical records on a cohort of ORC patients (N=3,021) receiving treatment at the Huntsman Cancer
Institute at the University of Utah, I will examine changes to metabolic health and metabolic obesity phenotype
over time, using both mixed effects models and multivariable logistic regression models, and identify predictors
of metabolic dysfunction. Results may help inform interventions and transform clinical practice guidelines for
the management of metabolic dysfunction following ORC diagnosis, and may improve the quality of life and the
survivorship experience of cancer patients. The objectives outlined in this proposal will provide me with
extensive experience in cancer and metabolism research, while contributing to the large knowledge gap of the
role of metabolic dysfunction on cancer progression. Furthermore, the combination of rigorous research
training in advanced epidemiologic and biostatistical methods, experiential learning, clinical context, and expert
mentorship will ensure my transition to a successful physician-scientist engaged in active research.

Public health relevance
PROJECT NARRATIVE. Despite the overwhelming evidence that metabolic dysfunction and obesity increase the risk of multiple cancers, evidence on whether these exposures are associated with survival after a cancer diagnosis is limited. Using both a large prospective epidemiologic cohort and electronic medical record data from a comprehensive cancer center, we will examine the relationship between obesity-related cancer and metabolic dysfunction after cancer diagnosis using metabolic obesity phenotypes. Results will potentially inform clinical care for cancer patients at highest risk of metabolic dysfunction and improve their survivorship experience.